Population genomics in peripartum cardiomyopathy

PROJECT SUMMARY
Peripartum cardiomyopathy (PPCM) is a form of heart failure characterized by left ventricular dysfunction
that occurs during late pregnancy or shortly after delivery. This condition causes a sudden weakening of the
heart muscle, leading to clinical heart failure and significant reductions in both quality and quantity of life. PPCM
remains a leading cause of maternal mortality, accounting for nearly a quarter of all deaths in the late postpartum
period. Despite its severe impact, the exact cause of PPCM is unknown, and it often arises in women without
identifiable clinical risk factors. Additionally, PPCM disproportionately affects women of self-identified Black race
and African descent, even after adjusting for ancestry-specific cardiac risk factors and socioeconomic disparities.
Recent studies have linked rare ("monogenic") variants associated with dilated cardiomyopathy (DCM), such as
truncating mutations in TTN, to PPCM in about 15% of cases. Moreover, polygenic risk scores (PRS), which
aggregate common genetic variants associated with DCM, have shown relevance to PPCM in a broader subset
of cases. Notably, we recently identified a common African ancestry-specific loss-of-function mutation in CD36
that accounts for a significant portion of DCM risk in AFR populations. However, it remains unclear: (1) How
combining monogenic and polygenic factors could enhance prediction and early detection of PPCM; and (2) The
extent to which CD36 variation explains the increased PPCM risk observed in AFR individuals.
This proposal aims to expand genomic investigation into PPCM by leveraging the national PPCM-
Registry (~470 participants, 40% of AFR ancestry) alongside additional recruitment and biobank data. We will
combine data from existing biobanks, where genetic data are available but phenotyping of PPCM is required,
and from newly recruited PPCM cases, where detailed phenotyping is available, but genetic data generation is
needed. This expanded dataset will provide added power for testing a priori hypotheses and discovering novel
PPCM associations, facilitating a more comprehensive understanding of genetic risk in PPCM.
Our study aims to: (1) Expand the PPCM-Registry and create a larger, consolidated genetic dataset by
integrating genetic and phenotypic data across biobanks and recruited cohorts; this will involve generating new
genetic data where needed and standardizing phenotypic data across cohorts to support discovery in this rare
condition. (2) Evaluate monogenic and polygenic risk factors for left ventricular dysfunction in all PPCM-Registry
participants to understand the combined effect of rare and common variants on PPCM risk. (3) Characterize
African ancestry-specific risk for PPCM, focusing on the contribution of the CD36 loss-of-function variant to
PPCM incidence among AFR participants, with additional analysis of its impact on observed disparities in PPCM
risk. Through this comprehensive approach, we aim to advance understanding of the genomic underpinnings of
PPCM to enhance prediction, early detection, prevention, and management of this serious cardiovascular
condition, while addressing significant disparities in risk.

Public health relevance
PROJECT NARRATIVE This current proposal aims to conduct a comprehensive investigation into the genomic underpinnings of peripartum cardiomyopathy (PPCM), enhanced by expanded case recruitment through existing biobanks and de novo efforts, alongside the national PPCM-Registry. Blood samples will undergo genome-exome sequencing, and genomic markers of left ventricular dysfunction from across the allele frequency spectrum—ranging from rare pathogenic variants to common variant (polygenic) scores—will be applied. Importantly, the analysis will include an African ancestry-specific risk variant at CD36 to assess its contribution to the disproportionate risk of PPCM in individuals of African descent and, along with other genome markers, will be evaluated in the context of clinical factors and longitudinal outcomes.